Genipin’s ECM Crosslinking Action as an Agent to Prevent Neurodegeneration in Familial Dysautonomia

Project summary/Abstract
Familial Dysautonomia (FD) is a severe genetic disorder affecting children, with no specific treatment. It involves
neurodevelopmental defects at birth and progressive sensory and autonomic neuropathy. Symptoms include
progressing loss of pain and temperature sensation, gait ataxia, and blindness. FD is caused by a mutation in
the ELP1 gene, reducing the Elp1 protein in peripheral neurons specifically; but decades of research on ELP1
have not yet yielded a treatment. Especially important, a post-birth treatment is needed to prevent further neuron
loss. Thus, exploration of alternative treatments, like targeting the extracellular matrix (ECM) are crucial. This
R01 renewal application follows a successful project that assessed the molecular mechanistic basis of disease
severity in FD and aimed at personalized therapies for FD. There, we discovered genipin, a compound of a
Traditional Chinese Medicine, which has shown promise in preventing neurodevelopmental defects and sensory
neuron death in FD by crosslinking ECM proteins. Our goal is to investigate genipin's mechanism of action and
its potential to prevent FD-related peripheral neuropathy in human and mouse models. Using transcriptomics
and proteomics analysis, we found the ECM and glycosaminoglycans (GAGs) downregulated and growth factors
upregulated in FD, possibly a compensation mechanism. Here, we will test if the ECM and GAGs are aberrant
in FD, using deep disaccharide analysis. We will assess if this consequently leads to aberrant growth factor
presentation and signaling issues, preventing proper development of sensory neurons -- and whether genipin’s
crosslinking action rescues that (Aim 1). We will assess genipin's ability to prevent neurodegeneration in a human
FD stem cell model, focusing on axon growth, cytoskeletal, and energy issues (Aim 2). Finaly, we will evaluate
genipin’s effect on the FD mouse model, testing for phenotype reversal and sensory neuron preservation (Aim
3). The outcomes could position genipin as a treatment for FD and other peripheral neuropathies, as there are
currently no FDA-approved drugs targeting these conditions.

Public health relevance
Project Narrative Familial Dysautonomia (FD) is a genetic disorder causing neurodevelopmental defects, progressive sensory neuropathy leading to loss of mobility. The natural compound genipin, used in Traditional Chinese Medicine, shows potential in preventing neuron death by crosslinking extracellular matrix (ECM) proteins and promoting axon regeneration via biophysical stiffening of the ECM. This study aims to investigate genipin's mechanism in human and mouse models with the goal of developing it as a treatment for FD and other neuropathies.